Free Text Gene Name Recognition

1) I have been a co-organizer of the BioCreative Workshops since 2005 and have taken part in BioCreative II (2007), BioCreative III (2010), BioCreative-2012 Workshop (2012), and BioCreative IV (2013) and my group is taking part in BioCreative V (2015) which has not yet taken place. The overall goal of the BioCreative Workshops is to promote the development of text mining and text processing tools which are useful to the communities of researchers and database curators in the biological sciences. 2) We are currently working to develop more general methods of finding high value articles for PPI based on their abstracts. This effort involves not only more powerful ranking methods, but also ways to display evidence to the user for a users quick evaluation. 3) We are also investigating an approach to named entity recognition for a large number of biologically important entity types. We have found certain general patterns that can be used to find genes and other entity types with a higher reliability than can be done with a general CRF. This is ongoing research with a promise for more useful general patterns. 4) We have begun a project called BioC which is an effort to create a general XML format defined by a DTD and software to read and write this format. Currently this approach has been implemented in C++, Java, Python, Pearl, Ruby, and GO. The idea is to use this common currency to make software modules that are useful for natural language processing more interoperable. The project is in its early stages, but already we have software to read and write in the languages mentioned as well as significant NLP processing modules using this approach and over 25 gold standard NLP annotated data sets available in the format. The approach was featured in the BioCreative IV Workshop and the approach has formed the basis of the BioC Collaborative Track at BioCreative V which will take place in a short time. This track has received contributions from eight teams besides our own and has built a user interface which displays annotated articles to Biogrid curators to assist them in their work.